Ketamine for The Rapid Treatment of Major Depression and Alcohol Use Disorder

Major depressive disorder (MDD) and alcohol use disorder (AUD) are serious mental illnesses and
commonly co-occur among Veterans. Adequate treatment of depression and comorbid AUD is of major clinical
importance at the VA, yet the efficacy of current pharmacotherapy for depression is only modest and remission
rates are particularly low in depressed patients with AUD. The delay of weeks or months before the onset of
antidepressant effects of traditional antidepressants is also problematic, particularly given the elevated risk for
suicide in this population. Furthermore, despite the fact that 40% of patients with MDD have comorbid AUD in
their lifetime, AUD patients have been excluded from most antidepressant trials for depression. Thus, there is a
critical need to develop effective pharmacotherapy for MDD and AUD.
There is a growing body of literature showing that a subanesthetic single intravenous (IV) infusion of
ketamine has rapid and robust antidepressant effects. Ketamine was also associated with a rapid reduction in
suicidal thoughts in randomized controlled trials. In addition to treating MDD, emerging evidence indicates that
ketamine, an NMDA receptor antagonist, might be an effective treatment for AUD by stabilizing glutamatergic
system. Building on this evidence, we recently tested ketamine in patients with comorbid MDD and AUD. Our
pilot data showed that ketamine may be safe and effective in reducing depression and alcohol consumption.
The primary goal of this proposal is to test repeated intravenous ketamine (0.5 mg/kg; once a week; a
total of 4 ketamine infusions) as a treatment for MDD and AUD in a total of 60 Veterans. We propose an 8-
week, randomized, double-blind, placebo-controlled trial. The study will have two phases: 1) a 4-week
treatment phase and 2) a 4-week follow-up phase. All patients will be evaluated daily by using ecological
momentary assessment and will receive usual standard care during this trial.
There are five objectives.
Aim #1: To evaluate whether ketamine is superior to active placebo (midazolam) in treating depression in
Veterans with comorbid MDD and AUD. We hypothesize that ketamine is superior to active placebo in clinical
response for treating depression. The clinical response will be defined as a ≥ 50% improvement from baseline
in Montgomery-Åsberg Depression Rating Scale (MADRS) score.
Aim #2: To evaluate whether ketamine is superior to active placebo (midazolam) in reducing alcohol use in
Veterans with comorbid MDD and AUD. We hypothesize that ketamine is superior to active placebo in
reducing drinking as measured by the Time Line Follow Back (TLFB).
Aim #3: To evaluate whether ketamine is superior to active placebo (midazolam) in reducing alcohol craving
during the 8-week study period. We hypothesize that ketamine is superior to active placebo (midazolam) in
reducing alcohol craving as measured by the Alcohol Urges Questionnaire (AUQ).
Aim #4: To evaluate whether ketamine is superior to active placebo (midazolam) in reducing suicidal ideation.
We hypothesize that ketamine is superior to active placebo (midazolam) in reducing suicidal ideation as
measured by the Columbia-Suicide Severity Rating Scale (C-SSRS) Suicidal Ideation category.
Aim #5: To evaluate the safety and tolerability of repeated ketamine infusions in Veterans with comorbid MDD
and AUD. We hypothesize that repeated ketamine infusions are safe and well tolerated in this population.
Conclusion: This is the first randomized controlled trial examining the therapeutic potential of repeated
ketamine for comorbid MDD and AUD. If successful, our pharmacological approach could help Veterans
suffering from this condition.

Public health relevance
There has been widespread public concern about depression, suicide, and alcohol abuse among military personnel and Veterans. Suicides in the U.S. military surged to a record high in 2012. An estimated 22 Veterans commit suicide every day in the United States, which led to a Veteran suicide prevention bill into law in 2015. In addition, binge drinking by active duty service members increased from 35% in 1998 to 47% in 2008. Veterans frequently have co-occurring alcohol problems and depression. Despite the enormous suffering and mortality, the efficacy of current pharmacotherapy is only modest. In this proposal, we will test ketamine for treating Veterans with depression and alcohol use disorder. Our project is highly relevant to the VA mission because it will target the VA’s research priority area such as: 1) Veteran-related psychiatric disorders, 2) suicide prevention interventions, and 3) substance abuse. If our study is successful, our approach could help Veterans suffering from depression and alcohol use disorder.